Drug Discovery for Alzheimer’s Disease Enabled by Multi-Omics and Artificial Intelligence

PROJECT SUMMARY/ABSTRACT
There is a fundamental gap in our understanding of how amyloid beta oligomers (AβO) induce neurotoxicity
and neuron death in Alzheimer’s disease (AD), as evidenced by a dearth of therapies to prevent or halt AD
progression. Continued existence of this knowledge gap represents a major issue for public health and the
mission of the NIH because, until it is filled, development of treatments for neurodegeneration in AD will remain
largely intractable. The long-term goal of this work is to discover pathways that enable resistance to AβO-
induced neurotoxicity thereby allowing discovery of new AD therapeutics. The overall objective here, which is
the next step in pursuit of this goal, is to build AI that accurately predicts the ability of drug candidates to cure
or prevent toxicity of AβO in human stem cell-derived cortical glutamatergic neurons. To train this AI, a library
of proteomic and metabolomic (hereafter referred to as multi-omic) phenotypes will be generated from neurons
that are: 1) healthy, 2) AβO-treated (AD-like), or 3) drug library+AβO-treated. The central hypothesis is that
some drugs at least partially palliate AβO-induced neurotoxicity, which is observable as a shift in multi-omic
state toward the healthy state, and that AI can learn to predict this curative potential from drug structures. This
hypothesis is based on preliminary data generated by the applicant and literature. The rationale for the
proposed research is that mapping the difference in multi-omic phenotypes of healthy and AβO-stressed
neurons, and mapping how chemical structures induce changes between those states, will allow AI to learn to
make accurate predictions of whether additional, unmeasured molecules can improve neuron health. This will
result in new and innovative approaches for prevention and treatment of AD. Guided by preliminary data and
literature, this hypothesis will be tested by pursuing two specific aims: 1) validate the multi-omic phenotype
landscape of healthy and AD-like neurons; and 2) build AI to discover new drugs that prevent AβO-induced
neuron death in AD. The first aim will validate the human disease relevance of our model system using cell-
based assays and by comparing omic profiles from our system to those observed in human AD brains. The
second aim will build a map of how drugs candidates alter neural multi-omic states to use for training predictive
AI. Completion of these aims will contribute (1) an in vitro system that mimics physiological milieu, and also (2)
molecular ‘omics’ signatures of those healthy and AD-like human iPSC-derived neural cells, which are two
areas of high program relevance defined in NOT-AG-19-007. This approach is innovative, in the applicant’s
opinion, because it departs from the status quo by using highly translatable human iPSC-derived neurons for
unbiased discovery of palliative drug candidates using a unique combination of multi-omics and AI. This
contribution will be significant because it is expected to vertically advance our understanding of basic neuron
stress resistance, as well as result in the first drugs that prevent AβO neural toxicity. Ultimately, such
knowledge will be useful for other neurodegenerative disorders of aging.

Public health relevance
PROJECT NARRATIVE The proposed research is relevant to public health because the discovery of new neural resilience mechanisms is ultimately expected to result in new therapeutics for Alzheimer’s disease. This project also produces molecular omics profiles from human iPSC-derived neurons, which will serve as a resource for Alzheimer’s disease researchers. Thus, the proposed research is relevant to the NIA’s mission to support biological research on aging and develop research resources.